MAE-WEST RSC - Eicosanoids Profiling Core

Project Abstract – MAE-WEST SCORE Eicosanoids Profiling Core
Over the course of life, chronic stressors contribute to multi-organ aging and dysfunction and, ultimately, the
development of clinical disease. Sex remains a critical determinant of the nature and pace of aging and ultimately
longevity. Among mammalian species, it is even more clear that females fundamentally age differently from
males. With advancing chronologic age in humans, differences in biological aging between women and men
become even more pronounced, culminating in the female predominance for a number of important morbid
disease conditions, including notably Alzheimer’s disease and related dementias (ADRD), heart failure with
preserved ejection fraction (HFpEF), progressive chronic kidney disease (CKD), and in turn systemic frailty.
Mechanisms underlying the female predominance for these major morbidities remains unknown and are not
explained by variations in sex hormones or survival bias. Our preliminary work supports a central hypothesis that
sexual dimorphism in inflammatory eicosanoid mediators contribute to sex differences in microvascular
dysfunction and, in turn, to sex differences in age-related multi-organ disease, including for ADRD, HFpEF and
CKD. Elucidating a common pathophysiologic basis for the female predominance of ADRD, HFpEF, and CKD
holds the key to effective interventions for reducing the excess burden of age-related disease in women. We
propose to establish the Microvascular Aging and Eicosanoids – Women’s Evaluation of Systemic aging Tenacity
(MAE-WEST) (“You are never too old to become younger!”) Specialized Center of Research Excellence
(SCORE) on Sex Differences, in response to NIH RFA-OD-19-013. Our goal is to form a robust and sustainable
structure of academic activities centered on systematically interrogating sex differences in the relationship
among eicosanoids, microvascular dysfunction, and age-related end-organ disease, with an initial focus on the
microvascular aging effects on brain, heart, and kidney function. This goal will be achieved by an outstanding
collaborative team of clinician-scientists (with expertise in geriatrics, cardiology, and nephrology),
epidemiologists, basic and translational scientists, analytical chemists, biostatisticians, and bioinformaticians.
Leveraging our collective experience, resources, and infrastructure, we will advance the scientific enterprise
through 3 foundational projects aligned and complementary yet independent. We will establish a dedicated
Resource Support Core - an Eicosanoids Profiling Core (EPC) that will be intentionally created as standalone
organization within the larger MAE-WEST SCORE. This organizational feature will not only maximize resource
sharing across the project aims but also ensure the ability to separately and independently augment the
methodological training of early career investigators and, importantly, timely provision of in-kind services for
trainee pilot projects. The dedicated effort of the EPC will allow efficient generation of preliminary data for
acquiring additional and ancillary grant funding for both early career and core activities, which will additionally
contribute to the long-term sustainability of the MAE-WEST SCORE as a whole.

Public health relevance
Project Narrative – MAE-WEST SCORE Eicosanoids Core With advancing age, women and men age differently; women suffer more from Alzheimer’s disease and related dementias, heart failure with preserved ejection fraction, chronic kidney disease, and frailty. Recent work suggests that small blood vessel-related aging driven by chronic low-grade inflammation may be responsible for these aging disparities for women. The Eicosanoid Profiling Core (EPC) in the Microvascular Aging and Eicosanoids – Women’s Evaluation of Systemic aging Tenacity (MAE-WEST) (“You are never too old to become younger!”) Specialized Center of Research Excellence (SCORE) on Sex Differences will analyses of pro and anti-inflammatory responses in the bloodstream to small vessel aging, maximize resource sharing across the project aims, and provide advanced research method training for early career investigators, which will additionally contribute to the long-term sustainability of the MAE-WEST SCORE to improve public health.